EFFECTS OF 0.16 AND 0.12 PPM OZONE ON AIRWAY INFLAMMATION IN ASTHMA

The purpose of this study is to determine the following aspects of the effect of ozone on asthmatics. To determine if ozone exposure induces eosinophil influx in the airways. To determine if ozone exposure causes increased bronchospasm in asthmatics and the time course of such changes after exposure. To determine if airway oxidant stress is increased as indicated by measures of expired breath H202.